Optimizing decision-making to improve maternal outcomes in high-risk pregnant patients with hypertensive disorders - Resubmission - 1

PROJECT SUMMARY/ ABSTRACT
Hypertensive disorders of pregnancy (HDP) are common conditions that cause significant maternal
morbidity during the birthing process. Guidelines encourage routine delivery management with induction of labor,
but my prior work demonstrated many patients across the US are not receiving this care, and instead have high
rates of cesarean delivery. This variation may occur because current guidelines lack specificity for patients with
HDP complications or factors that increase risk of induction of labor, where it is unknown if induction of labor
continues to be favored. My preliminary data from NYU reports up to 20% of those undergoing induction for HDP
develop abnormal vital signs, lab abnormalities, or symptoms consistent with progression of HDP. However, it is
unknown how the risks of induction of labor compare to those of immediate cesarean delivery. Without a more
nuanced understanding of how delivery decisions and clinical factors influence outcomes, too many may be
receiving a potentially unnecessary cesarean delivery (when induction of labor would have improved
outcomes), or experiencing potential excess morbidity from induction of labor, when immediate cesarean
delivery may have been favored.
This proposal will characterize the risks of each delivery decision with more precision and potentially
develop a decision model to guide individual-level decision making. To accomplish this, in Aim 1 we will use a
large representative dataset to compare maternal health outcomes among comparable newly diagnosed
patients with HDP based on delivery decision (induction of labor versus immediate cesarean delivery). In Aim 2
we will potentially develop a decision model for delivery decisions between induction of labor and immediate
CD, incorporating patient preferences and long-term health outcomes. In Aim 3 we will identify perceived
clinical, structural, and cognitive factors informing delivery through clinician focus groups and patient
interviews. I have assembled a mentorship team, led by Dr. Scott Braithwaite, with the expertise to supervise
this research proposal and its corresponding training objectives. My training objectives are to 1) develop
advanced skills in perinatal epidemiology and causal inference techniques 2) acquire expertise in decision
science incorporating advanced risk prediction and 3) train in qualitative and mixed methods, conducting focus
groups and patient interviews, coding, and analyzing qualitative data. My long-term career goal is to become
an independent physician scientist with a research program that focuses on improving risk prediction and
clinical decision-making in hypertensive disorders of pregnancy. The proposed training and research plan will
prepare me to succeed as an independent investigator.

Public health relevance
PROJECT NARRATIVE High blood pressure during pregnancy can lead to serious health complications during the birthing process, making the decision between attempting vaginal birth (through an induction of labor) or proceeding with cesarean delivery very critical. This study will identify the benefits and risks of each birthing option from multiple perspectives and create a framework that can help predict which approach is better for each patient. This will lead to patients receiving more personalized and safe medical care.